1/2 PREEMPT: Prospective RandomizEd Evaluation and Management of Premature aTherosclerosis

Failure to detect and treat atherosclerosis in younger adults worsens cardiovascular morbidity and mortality.
Current strategies of assigning preventive therapies are not based on screening for atherosclerosis, but rather
on short-term risk scores that heavily weight age and leave most at-risk young and middle-aged adults
untreated. A new paradigm of screening for and identifying subclinical atherosclerosis via coronary computed
tomography angiography (CCTA) is emerging because subclinical atherosclerosis has prognostic superiority
over traditional risk scores. However, it is still unknown how best to screen for and identify younger adults who
have subclinical coronary atherosclerosis, and how best to treat them to reduce atherosclerotic burden. Both
LDL-C and inflammation are causal in the pathogenesis of atherosclerosis, but it is unknown whether treating
either or both processes in younger individuals can effectively and safely reduce atherosclerotic burden.
The PREEMPT (Prospective RandomizEd trial of the Evaluation and Management of Premature
aTherosclerosis) study will address this urgent public health need by determining optimal strategies to screen
for, identify, and treat subclinical coronary atherosclerosis in young and middle-aged adults. Aim 1 will focus on
screening younger adults for subclinical coronary atherosclerosis. We will evaluate the effectiveness of three
strategies to detect coronary atherosclerosis in young and middle-aged adults (women aged 40−60 and men
aged 30−50) at low 10-year, but high lifetime risk. These strategies will include an electronic health record
search, outreach to family members of those with premature heart disease, and community outreach/social
media. The outcome will be proportion screened with coronary artery calcium (CAC) score >0. An adaptive
design will be utilized to modify or eliminate ineffective strategies.
Aims 2 and 3 will focus on assessing the efficacy and safety/tolerability of 3 therapeutic strategies to reduce
atherosclerotic burden. Individuals who meet clinical eligibility criteria through the screening study, or
opportunistically through preexisting imaging evidence of coronary calcification, and have a CAC score of 1−99
will undergo CCTA to confirm presence of measurable non-calcified plaque (NCP) volume, and will then be
randomized to a placebo-controlled, double-masked, 2x2 factorial randomized trial of rosuvastatin 20mg,
colchicine 0.5mg, or the combination vs. placebo. All participants will also receive a state-of-the-art mHeath
behavioral intervention to ensure lifestyle modification for all participants. The primary endpoint will be centrally
adjudicated NCP volume on CCTA at 2 years, adjusting for baseline NCP volume.
If successful, PREEMPT will reduce the unacceptably high morbidity and mortality of cardiovascular disease
by providing randomized trial evidence supporting a paradigm shift away from a 10-year risk-based prevention
strategy and towards earlier detection and treatment of subclinical atherosclerosis in younger adults.

Public health relevance
The goal of the PREEMPT trial is to understand how best to screen for and treat plaque in heart arteries among young- and middle-aged adults who appear to be low-risk, but are actually at high risk of heart disease given the presence of plaque. In the screening study, three strategies to identify calcium in the heart arteries of previously undiagnosed adults will be compared. In the treatment trial, individuals with plaque in their heart arteries will be randomized (like the flip of a coin) to a medication that lowers cholesterol, one that lowers inflammation, the combination of both, or neither (placebo) to understand the effect of these treatments on reducing plaque over two years.